Nuclear Dynamics and Cancer Program

PROJECT SUMMARY/ABSTRACT – NUCLEAR DYNAMICS AND CANCER PROGRAM
The Nuclear Dynamics and Cancer (NDC) program was created in 2022 following a series of Center-wide
retreats and strategic planning sessions. The Program brings together several thematic elements that had been
housed in three previous Programs: Cancer Signaling and Epigenetics, Molecular Therapeutics, and Blood Cell
Development and Function. The NDC Program was intentionally crafted to promote potential synergies among
these themes, such as the role of cancer-related epigenetic changes in modulating the specification of immune
cell function, the effect of nuclear 3D architecture on gene expression and on genome stability (and vice-versa),
and the mechanisms by which epigenetic plasticity contributes resistance to chemotherapies and to targeted
therapies. The Program is led by Tomasz Skorski and Johnathan Whetstine. Together they bring highly
complementary expertise to support the NDC mission: Skorski focuses on DNA damage and repair, particularly
with regard to myeloid malignancies. Whetstine focuses on histone methylases and demethylases and their role
in regulating oncogene amplification. The themes of the Program are 1) Genome Integrity: mechanisms
impacting cancer and non-cancer cell genome and epigenome; 2) Gene Regulation: processes that control
gene expression related to tumorigenesis; 3) Mechanistic relationships between Epigenetics and Drug
Response. NDC comprises 33 members who are supported by $6.7M (DC) in total peer-reviewed grant funding,
of which $3.1M is from NCI. The new NDC Program is complementary to, but distinct from, the new Cancer
Signaling and Microenvironment (CSM) Program. The NDC Program addresses several primary goals as
enunciated in FCCC’s strategic plan. First, it is designed as a “full-spectrum” Program; that is, it spans
fundamental bench science all the way to clinical trials. Second, it is intentionally constructed to address the
needs of our Catchment Area, focusing attention on cancers that have elevated incidence and/or mortality among
this population. The Program also has developed deep, bidirectional ties to our community through formal
mechanisms that include Program Liaisons, Community Ambassadors, and various public educational events.
Third, the Program is responsive to new scientific developments that point to profound links between epigenetic
changes to histones and DNA, gene expression, and genome stability/nuclear architecture. By combining these
themes in one program, we hope to stimulate synergistic interactions and uncover new therapeutic strategies.
While the Program is relatively new, it has already shown great progress. Since its inception in 2022, five new
laboratory-based Assistant Professors have been hired to join the NDC Program. An impressive one-third of all
publications from members of this Program were published in journals with >10 impact factor. Twenty-eight
interventional clinical trials were open during the period of 10/1/2022-9/30/2023 based on science from this
Program, including those that test inhibitors of DNA methylases and demethylases, DNA repair enzymes, and
combinations of epigenetic therapies with immune checkpoint inhibitors and conventional chemotherapy.